Oncogenic Kras drives stromal adipogenesis to promote colorectal cancer (CRC) progression

Project Summary
While the 5-year survival rate for colorectal cancer (CRC) patients with localized stage disease (as defined
by SEER) is 90%, this survival rate drops to 14% for patients diagnosed with metastatic CRC. Thus, there is an
urgent need to define the mechanisms governing progression to advanced disease and its maintenance.
Human CRCs harboring oncogenic mutations in the KRAS oncogene (designated hereafter as KRAS*) are
25% more likely to develop metastases. Similarly, our CRC mouse model, engineered with an inducible KRAS*
transgene and conditional null alleles of APC and p53 alleles (iKAP), has revealed a role for KRAS* in driving
cancer progression and metastasis. Mechanistically, KRAS*-driven cancer metastasis functions in part by
activating cancer cell-intrinsic TGFβ signaling and suppressing anti-tumoral immunity via the IRF2-CXCL3 axis
which recruits myeloid derived suppressor cells. Unfortunately, emerging therapies targeting either KRAS* or
TGFβ pathways have shown limited efficacy in the clinic, motivating us to identify and validate additional
KRAS*-driven cancer progression mechanisms with the goal of expanding the repertoire of therapeutic targets
for metastatic CRC. Utilizing the iKAP model, functional gene set enrichment and histological analyses of
KRAS*-expressing CRC metastases revealed a strong adipogenesis signature and preponderance of
lipofibroblasts and angiogenesis in the tumor microenvironment. Correspondingly, co-culture of mouse
embryonic fibroblasts with conditioned media from iKAP primary cell lines stimulated their differentiation into
cells with adipocyte and fibroblast traits, i.e., “lipofibroblasts.” In the F99 phase of this proposal, I seek to define
the molecular mechanisms by which KRAS*-expressing cancer cells drive lipofibrogenesis and to understand the
tumor biological role of lipofibroblasts in KRAS*-driven CRC progression.
As only a minority of human or mouse KRAS* CRC cases progress to metastatic disease, clearly genetic
events beyond KRAS activation drive metastases. For example, patients with or without KRAS* mutation both
show around a 40% lymph node metastatic rate. The study of such pro-metastasis events would be greatly
facilitated by incorporating an inducible telomerase reverse transcriptase (LSL-mTERT) into our existing iAP
model, thus modeling telomere-based crisis and genome instability followed by telomerase reactivation. In our
telomerase-inducible mouse models of prostate cancer, crisis-telomerase sequence generates cancer-relevant
genomic aberrations and increases metastatic potential. Although incorporation of genomic instability into the
iAP model would not create a more human-like model, it would provide a platform to identify amplifications and
deletions associated with the metastatic process. In the K00 phase of this proposal, I seek to engineer human-
like telomere dynamics in the iAP model to assess the impact of telomere-based crisis and telomerase
reactivation in driving metastasis and to survey the genomic alterations that may underlie the metastatic process.
Such efforts may facilitate the discovery of new therapeutic targets for advanced CRC disease.

Public health relevance
Project Narrative Current targeted therapies for metastatic CRC patients show limited positive outcome, especially in KRAS*-driven metastatic CRC patients where KRAS* bypasses targeted therapies to activate downstream survival, proliferation and cell cycle progression signaling. Understanding the molecular and cellular biological mechanisms of CRC progression will ultimately lead to new targets to prevent or treat advanced disease and prolong survival of metastatic CRC patients. This proposal seeks to investigate 1) the interplay between KRAS*- driven cancer cells and carcinoma-associated stroma, and 2) the impact of telomere dynamics and associated genomic events that promote metastatic CRC, in order to precisely design new targeted therapies and further advance public health.